A Lead Academic Participating Site in Oklahoma for the Design and Conduct of NCTN Clinical Trials

Abstract
The Stephenson Cancer Center (SCC) at the University of Oklahoma Health Sciences Center (OUHSC) plays
a crucial role in providing Oklahomans with access to National Clinical Trials Network (NCTN) and other
clinical trials, thereby helping to raise the standard of care in the State and region. At the national level, the
SCC has provided significant leadership in the design and conduct of NCTN clinical trials. In 2014, the SCC
was designated a Lead Academic Participating Site (LAPS) in the NCTN. Since that time, it has worked to
advance the following Specific Aims: (1) providing scientific leadership and coordination with NCTN
components to design and conduct NCTN clinical trials for newly developed therapies, including multi-modality
treatments, combinations of novel agents, molecularly based treatments, Precision Medicine screening, and
advanced imaging approaches; (2) effectively integrating scientific expertise and clinical trials management
capabilities at the SCC in order to activate, conduct and complete NCTN clinical trials in an efficient, timely and
compliant manner; and (3) accomplishing Aims 1 and 2 within the context of providing high-quality cancer care
and access to NCTN clinical trials for all Oklahomans, with a special emphasis on the State's underserved
populations which experience disproportionately high rates of cancer health disparities. To advance Aim 3, the
SCC utilizes patient navigators, social workers and targeted educational information to address barriers to
enrolling patients on NCTN and other clinical trials. Specifically, the SCC has implemented an innovative
American Indian (AI) Patient Navigation program to serve the Oklahoma's large AI population and promote
enrollment to NCTN and other clinical trials for this population under-represented in clinical research.
Clinical research activities at the SCC are overseen by a well-defined governance structure and supported by a
centralized Clinical Trials Office (CTO) that manages regulatory, data management, study coordination,
informatics, quality assurance, and biospecimen acquisition for all cancer clinical trials. The CTO functions as a
core resource and receives funding from a variety of sources in addition to clinical trial direct cost dollars,
allowing it to be proactive in faculty and staff education and career development, and leading to enhanced
expertise and support capabilities. The collective knowledge base and cross-training within the CTO allows for
adequate staffing and knowledge at all levels of research activity and ensures a coordinated research team
approach for clinical research. The SCC is a Main Voting Member for NRG Oncology and the Alliance for
Clinical Trials in Oncology, and it is a Full Member of SWOG and ECOG-ACRIN Cancer Research Group. It
has worked efficiently and expeditiously with the respective Network Group operations, data management, and
statistical centers to accomplish the Specific Aims of the grant.

Public health relevance
Relevance Statement This proposal is directly relevant to public health. As a Lead Academic Participating Site in the National Clinical Trials Network (NCTN), the Stephenson Cancer Center will directly contribute to the design and conduct of NCTN clinical trials for newly developed therapies, including multi-modality treatments, combinations of novel agents, Precision Medicine screening, and advanced imaging approaches. The overall goal is to improve cancer patient outcomes and reduce the burden of cancer for all populations, with an emphasis on underserved populations in Oklahoma.